POSTTRANSCRIPTIONAL REGULATION OF VIRAL GENE EXPRESSION

Complex transcription units encode primary transcripts which can be differentially spliced and 3' end processed to yield different functional mRNAs. We have been using two model systems, adenovirus and HIV-1, to study the mechanisms which regulate alternative processing.